Novel TYRO3 inhibitors for treatment of cancer

TYRO3 is a member of the TAM (TYRO3, AXL, MERTK) family of receptor tyrosine kinases. All three
family members are aberrantly expressed in cancer cells, where they function to promote cell survival, mediate
resistance to a variety of cytotoxic chemotherapies and molecularly-targeted agents and have additional roles in
macrophages and other innate immune cells where they function to suppress anti-tumor immunity, leading to
enhanced tumor growth and metastasis. These and other data implicate the TAM kinases as potential
therapeutic targets in a wide variety of human tumors. Moreover, because of the oncogenic roles for TAM kinases
in both tumor and immune cells, inhibitors are expected to provide anti-tumor action mediated by both direct
tumor cell killing and modulation of the innate immune response. While the TAM kinases have overlapping
functions, they also play unique roles in some contexts. Specifically, our preliminary data suggest that
suppression of anti-tumor immunity is particularly dependent on TYRO3.
Here, we propose to utilize a well-established and productive team of researchers along with
computational-aided drug design and enzymatic, cell-based and pharmacodynamic assays to develop novel,
potent, and selective TYRO3 inhibitors and validate their biochemical and functional activities in TYRO3-
dependent tumor xenograft models and immune-competent syngeneic cancer models. TYRO3 can localize to
the nucleus and inhibition of nuclear localization induced apoptosis in colon cancer cells, suggesting non-
canonical oncogenic functions for TYRO3 which might not be effectively targeted by kinase inhibition alone.
Thus, both traditional small molecule kinase inhibitors and proteolysis-targeting chimeric (PROTAC) degraders
that selectively target TYRO3 for ubiquitination and degradation will be developed and compared. At the
completion of this work, we expect to deliver a TYRO3-selective inhibitor suitable for advancement to GLP toxicity
studies in multiple species, sufficient preclinical validation studies to support an IND application describing this
compound, and a viable method for large-scale synthesis of the compound.

Public health relevance
Approximately two-thirds of patients diagnosed with cancer in the United States will be cured of their disease using a combination of surgery, radiation and chemotherapy, but progress towards enhanced survival in adults with advanced and metastatic disease has been painfully slow, even in the era of targeted therapies, and new, more effective therapies are desperately needed. TYRO3 is a member of the TAM-family of receptor tyrosine kinases that is aberrantly expressed, promotes tumor cell survival and/or proliferation, and has been associated with poor prognosis in numerous human cancers, including melanoma, colorectal carcinomas, and lymphoma. Our preliminary data also suggest that agents targeting TYRO3 may be particularly useful for immuno-oncology applications, therefore, the studies described here aim to develop potent and selective TYRO3 inhibitors suitable for clinical application and as such, may have a direct impact on outcomes and/or quality of life for patients with advanced cancers.